Mentorship in Clinical Complementary and Integrative Health Research

Because over 50% of adults in the United States take complementary and integrative health (CIH) natural
products for their health, the training of CIH practitioners and scientists to produce high-quality clinical research
is imperative to identifying effective products for the safety of the public. As such, this proposal requests a K24
mid-career development award to expand and support mentorship in clinical natural product research by Dr.
Ryan Bradley, ND, MPH. Dr. Bradley has demonstrated effective mentorship by the publication of all past
mentees, and the progression of multiple mentees from graduate students to formal NIH post-doctoral training
awards, and independent training awards. Dr. Bradley is currently a Program Director and mentor in the NCCIH-
funded T90/R90 Building Research across Interdisciplinary Gaps (BRIDG) clinical research training program
formed in partnership between the University of Washington (UW) and the National University of Natural
Medicine (NUNM). Dr. Bradley provides mentorship for 10 post-doctoral trainees, including CIH clinicians and
PhD scientists. Dr. Bradley is a primary mentor for a T90 trainee who has progressed onto a KL2 award at the
UW, a CIH practitioner who received a NICCH administrative supplement to gain research experience on Dr.
Bradley's R01-funded clinical trials, and a T32 post-doctoral trainee in the ORCCAMIND T32 program at Oregon
Health & Sciences University (for which Dr. Bradley is a formal mentor). In addition to his positions as Director
of Research, Senior Investigator and Associate Professor at the NUNM, he retains affiliate and adjunct
appointments at 3 US-based and 2 international universities, thus Dr. Bradley is extremely well connected to
assist mentees in identifying resources and collaborators for their research. The Specific Aims of this proposal
are for Dr. Bradley to: 1. Dedicate consistent effort in the mentorship of promising trainees in T32, T90, R90, and
KL2 programs in order to facilitate their progression in research training and independent research (Aim 1); 2.
Refine and develop mentoring skills by pursuing additional training in: mentorship; diversity, equity and inclusion
in research; and cutting-edge translational science methodologies (Aim 2); and 3. Provide exposure to
translational science methods and provide publication opportunities for mentees through the collection of
additional preliminary data related to recent clinical trials of specialized pro-resolvin mediators (SPM) and
xanthohumol natural products, including product quality assessment, measurement of relevant biomarkers in
stored biologic samples, and measurement of additional transcription factors (PCSK9) to extend the research to
new clinical populations (Aim 3).

Public health relevance
The general goal of this proposal is to support Dr. Ryan Bradley's ability to mentor emerging clinical complementary and integrative health researchers and to advance the field of natural products research. This will be done by allowing Dr. Bradley to gain additional training in mentorship, reduce his administrative responsibilities to allow focus on mentorship, and work with trainees to generate new results and publications from recently completed clinical research toward new grant applications. From a practical perspective this proposal will lead to more qualified CIH clinical researchers and improved clinical trials of natural products.